Project 4

Diabetes is one of a broad range of human diseases and disorders that are directly associated with endoplasmic reticulum (ER) malfunction. This malfunction is termed

Public health relevance
RELEVANCE (See instructions): This project investigates how a protein involved in the onset of type 2 diabetes functions at the molecular level. Through these studies we aim to gain insights into how the protien, called GRP78, functions in the diabetic state and determine if the protein is a viable target for new therapeutics in the future.